TRANSIENT RECEPTOR POTENTIAL VANILLOID 6 (TRPV6) ANKYRIN REPEAT DOMAIN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Transient receptor potential (TRP) proteins are cation channels composed of a transmembrane domain flanked by large N- and C-terminal cytoplasmic domains. All members of the vanilloid family of TRP channels (TRPV) possess an N-terminal ankyrin repeat domain (ARD). The ARD of mammalian TRPV6, an important regulator of calcium uptake and homeostasis, is essential for channel assembly and regulation. Determining the structure of the TRPV6-ARD will allow us to compare its structure and biochemical properties to those of the TRPV1 and TRPV2 proteins previously determined in our lab.